Extraction of Vital Signs using a Telehealth Application for Asthma - EViTA-AThe purpose of this grant is to evaluate mobile devices to extract vitals signs to monitor patients with Asthma

Asthma is a chronic disease that affects quality of life, productivity, and healthcare use, and can
ultimately lead to death. The costs of asthma are largely due to uncontrolled disease and
accordingly rise as its prevalence and severity increase. Unfortunately, the incidence and impact
of asthma attacks have not improved despite widespread adoption of effective universal treatment
guidelines by healthcare providers, revealing an unmet need to facilitate implementation and
monitoring of large groups of asthma patients. We seek to improve the detection of the presence
and severity of an asthma attack for proper triage of patients to receive immediate medical
treatment versus continued observation at home. Telemedicine provides an opportunity for better
management, but these visual and verbal evaluations are often incomplete without vital sign
measurements. Our approach of remote monitoring with video-based vital sign capture offers a
game-changing alternative to address asthma attacks upon their initial presentation and
prevention through improved management of chronic asthma symptoms. This innovative
technology will: (i) extend the reach for physicians and accessibility for patients; (ii) improve
efficiency of healthcare delivery to the highest risk patients; (iii) limit exposure to infectious
disease for both patient and provider; and (iv) utilize common (relatively) commercial off the shelf
(COTS) technologies instead of expensive boutique equipment. The distinguishing characteristics
of asthma (inflammation, airway hyperreactivity and remodeling) are the expression of a unique
and complex set of molecular interactions that also manifest as symptoms and changes in
behavior that result in observed clinical phenotypes. Our next steps are to enhance remote
medical monitoring with extracted vital signs by developing a biopsychosocial approach to refine
phenotypes of asthma. Ultimately, the approach here will enhance the data gathered from each
digital touchpoint to improve early detection of acute health status before more costly
interventions are needed, thereby improving quality of life, and providing lower SES patients with
asthma or other respiratory illnesses a more viable means to obtaining access to healthcare.

Public health relevance
Improving access to healthcare technology can help address obstacles to care associated with socioeconomic status (SES), demographics, and age, where travel to a clinic is complicated by cost, limitations with transportation, and safety concerns related to transmissible infections. We aim to transform asthma management through deployment of a telemedicine application, targeting at risk and underserved populations, to enhance data gathered from remote visits with vital signs extracted from video, cognitive assessments, and data from wearable sensors. A multidimensional approach will be used to refine clinical phenotypes for asthma that can be used to develop endotypes to help forecast near-term outcomes and manage healthcare utilization.